Advancing Child Health: Preparing the Next Generation of Pediatric Researchers

Project Summary/Abstract
The objective of this proposed program is to provide advanced training and skill development required for
future leaders in basic, clinical, and translational child health research to upper level undergraduate students,
grooming them to serve as the next generation of innovators in pediatric research. In line with the mission of
the NICHD, these young scholars will train with mentors dedicated to pioneering advances that ensure children
lead healthy and productive lives, free from disease or disability, from birth to adulthood. The proposed
research education program is designed to expand and supplement a 10-week summer pediatric research
internship at The Children's Hospital of Philadelphia (CHOP) – the CHOP Research Institute Summer Scholars
Program (CRISSP) - with the ultimate goal of creating uniquely qualified students who are primed to both
succeed in and foster the biomedical research workforce pipeline. The program, which provides mentored
research training to 25 competitively-chosen student interns annually, will achieve this goal by expanding
curriculum in four key elements. These include technique mastery, exploration of career trajectories,
mentorship training and pipeline-building focused on diversity recruitment. In addition to enhanced student
training, a formal support for junior faculty will be developed to provide them with advanced mentorship training
and skills, enhancing both their support of the CRISSP scholars and their ability to skillfully support other
current and future mentees. These proposed enhancements, unique to the CHOP summer internship
program, will create an exceptional cadre of young scientist-leaders, gifted with an appreciation for pediatrics
and child health research in-line with the mission of the NICHD, technical proficiency, the importance of career
and research mentoring, and the value of diversity.

Public health relevance
Project Narrative The Children's Hospital of Philadelphia Research Institute Summer Scholars Program (CRISSP) is focused on advanced skill development to ensure that the best and brightest advanced undergraduates (juniors and seniors) are fully prepared for careers in biomedical research with an emphasis on areas directly relevant to the mission of the NICHD. CRISSP, places these talented upper level undergraduate students in a rich pediatric-focused environment where they will receive direct hands-on research experience, didactic sessions and mentoring to not only inspire them to pursue careers in basic, translational and clinical pediatric research but also to develop advanced skills that are essential to performing cutting-edge research to promote the health and well-being of children and to propel them forward as leaders and innovators in child health research. The program emphasizes practical skill development, mentorship and underrepresented minority (URM) recruitment into the field.